Biology of Rickettsia

Rickettsia rickettsii is the tick-borne etiologic agent of Rocky Mountain spotted fever. R. rickettsii is the prototypic spotted fever group rickettsia. Several other species, R. conorii, R. siberica, R. japonica, R. akari, and others cause diseases of lesser severity. Still other species in the spotted fever group, R. montana, R. peacockii, R. belli, and R. rhipicephali, are considered avirulent as they have never been associated with human disease nor do they cause overt disease in standard laboratory animals. The typhus group of rickettsia, typified by R. prowazeki, the agent of epidemic typhus, include some of the historically most devastating disease agents known to mankind. The typhus group also includes species of lesser or no virulence potential to humans. R. prowazeki and R. rickettsii are classified as Biodefense Catagory B and C agents, respectively. Rickettsia rickettsii is a member of the spotted fever group rickettsiae and the etiologic agent of Rocky Mountain spotted fever (RMSF). R. rickettsii is a small obligate intracellular Gram-negative organism maintained in its tick host through transovarial transmission. Infection with R. rickettsii occurs through the bite of an infected tick. Once the organism gains access to the host it is able to replicate within the host vascular endothelial cells and spread from cell to cell by polymerizing host cell actin. Damage to vascular endothelial cells by R. rickettsii leads to increased vascular permeability and leakage of fluid into the interstices causing the characteristic rash observed in RMSF. Infection with R. rickettsii results in a severe and potentially life threatening disease if not diagnosed and treated properly. While much is known about the progression of disease, the molecular mechanisms involved in the pathogenesis of RMSF are poorly understood. Strains of Rickettsia rickettsii vary dramatically in their virulence in animal model systems and severity of human disease. The obligate intracellular lifestyle of rickettsiae and the lack of tractable genetic systems make it difficult to identify genes involved in virulence. With the completed sequences of multiple rickettsial species, it has become possible to investigate differences between virulent and avirulent strains of rickettsiae through comparative genomics. In a guinea pig model of infection, the severity of disease as assessed by fever response varies from the most virulent, Sheila Smith, less virulent Morgan and Sao Paulo, moderate virulence for the R strain, low for HLP, and Iowa which causes no fever. Plaque morphologies also vary in size and degree of host cell lysis. To identify genes involved in the virulence of R. rickettsii, the genomes of four different strains were resequenced by comparison to known genome sequences (CGS). R. rickettsii Morgan, HLP, R and Sao Paulo strains were compared to avirulent strain R. rickettsii Iowa and virulent R. rickettsii Sheila Smith. SNP analysis revealed the Montana strains Sheila Smith and R to be highly similar while the Eastern strains Iowa and Morgan were more similar to each other. Sao Paulo appears to be most like the Montana strains, whereas HLP contained too many differences to categorize. The region of ompA containing 13 tandem repeats was sequenced using the transposon system EZ-TN5 revealing only 7 shared SNPs (4 nonsynonymous) for R and Morgan strains compared to Sheila Smith with an additional 16 SNPs identified in Morgan. Analysis of rompB, another major surface antigen, shown in Iowa to have a defect in processing, reveals identical sequences between Iowa and Morgan and R being identical to Sheila Smith. By immunoblotting, both rOmpA and rOmpB appear similar among the more virulent strains, whereas Iowa and HLP do not. The number of coding sequence SNPs between sequences is low, narrowing the field of possible virulence factors. Strains of Rickettsia rickettsii, the causative agent of Rocky Mountain spotted fever (RMSF), differ dramatically in virulence despite >99% genetic homology. Spotted fever group (SFG) rickettsiae produce two immunodominant outer membrane proteins, rOmpA and rOmpB, which are conserved throughout the SFG and thought to be fundamental to pathogenesis. rOmpA is present in all virulent strains of R. rickettsii but is not produced in the only documented avirulent strain, Iowa, due to a premature stop codon. We created of an isogenic ompA mutant in the highly virulent strain, Sheila Smith, by insertion of intronic RNA to create a premature stop codon 312 bp downstream of the 6,747 bp open reading frame initiation site. Targeted insertion was accomplished using an LtrA group II intron retrohoming system. Growth and entry rates of Sheila Smith OmpA in Vero cells remained comparable to wild type. Virulence was assessed in a Guinea pig model by challenge with 100 PFU of either OmpA Sheila Smith or wild type but showed no significant difference in either fever peak (40.5C) or duration (8 days) between wild type and knockout. The ability to disrupt genes in a site-specific manner using an LtrA group II Intron system provides an important new tool for evaluation of potential virulence determinants in rickettsial disease research. Rickettsia rickettsii, the causative agent of Rocky Mountain spotted fever, contains two immunodominant proteins, rOmpA and rOmpB, in the outer membrane. These proteins make up a significant portion of the outer membrane proteome and S-layer. Both rOmpA and rOmpB are conserved throughout the spotted fever group rickettsia as members of a family of autotransporter proteins. Previously, it was demonstrated that rOmpB is proteolytically processed with the cleavage site residing near the autotransporter domain at the carboxy-terminal end of the protein, cleaving the 168 kDa precursor into apparent 120 kDa and 32 kDa fragments. The 120 and 32 kDa fragments remain non-covalently associated on the surface of the bacterium with implications that the 32kDa fragment functions as the membrane anchor domain. Here we present evidence for a similar post-translational processing of rOmpA. A small rOmpA fragment of 32kDa was discovered during surface proteome analysis via mass spectrometry and identified to the carboxy terminal end of the protein. A rabbit polyclonal antibody was generated to the autotransporter region of rOmpA and identified a 32kDa peptide corresponding to the calculated mass of a proteolytically cleaved rOmpA autotransporter region. N-terminal amino acid sequencing revealed a cleavage site on the carboxy-terminal side of Ser-1958 in rOmpA. The amino acid sequence of the cleavage site of rOmpA was 54.5% similar to rOmpB small fragment suggesting a single enzyme may be responsible for both processing events. Available mass spectrometry data and protein analysis has demonstrated that the putative rOmpA C-terminal fragment is present in all virulent strains of R. rickettsii to date. Complementation of the avirulent Iowa strain of R. rickettsii with proteins identified in genomic comparisons revealed a secreted effector protein that associates with host cellular membranes.